Investigating the protective role of stress granules in cardiomyocytes

ABSTRACT
Ischemia-reperfusion injury occurs when the heart tissue’s demand for oxygen and nutrients fails to be met by
blood flow inducing oxidative stress, inflammation, and cell death. The heart is primarily comprised of post-
mitotic, non-regenerative cardiomyocytes, so it is necessary for these cells to recover from stress without
inducing cell death to minimize the extent of tissue damage and maximize recovery of cardiac function. Other
cell types respond to similar stress by assembling stress granules, which are transient, phase separated droplets
of mRNA and RNA binding proteins in the cytosol. Stress granules are largely associated with protective function
by several proposed mechanisms but can also be maladaptive. Rigorous direct tests of their function are lacking,
especially in the context of the heart. Some reports indicate that the myocardium is partially protected from
ischemia-reperfusion injury by activation of the Integrated Stress Response signaling pathway, which causes
stress-induced stalling of translation, leading the stress granule assembly. However, it is unknown if activation
of the integrated stress response leads to stress granule assembly in the heart, and if stress granules may
protect or harm the heart during stress. My preliminary data demonstrates that stress granules assemble in
several models of cardiomyocytes and in response to several stress types, including ischemia-reperfusion injury.
Based on the reported protection of the myocardium by activation of the integrated stress response and my
preliminary data, I hypothesize that stress granules assemble in cardiomyocytes after activation of the integrated
stress response to promote cell viability. To approach this, in Aim 1, I will determine the dynamics of stress
granule assembly and disassembly in cardiomyocytes and their dependence on activation of the integrated
stress response. I will induce oxidative stress and simulate ischemia reperfusion injury in primary cardiomyocytes
and use live cell and super resolution imaging of stress granule components and monitor markers of integrated
stress response activation. I will also use small molecule perturbations of integrated stress response activation
and stress granule assembly to test the interdependence of stress granules and the integrated stress response.
In Aim 2, I will test if stress granules protect cardiomyocytes from ischemia-reperfusion injury. Using bi-directional
modulation of stress granule assembly in primary cardiomyocytes, I will elucidate the specific contributions of
stress granules to cardiomyocyte viability. I will also develop a mouse model of cardiac-specific stress granule
assembly prevention and model ischemia-reperfusion injury to assess effects of stress granules on extent of
cardiac tissue damage and cardiac function. Completion of these aims will be first investigation of stress granule
dynamics and function in cardiomyocytes, and will determine if stress granules have a protective, maladaptive,
or incidental function in cardiac stress, potentially identifying a novel therapeutic strategy for minimizing
cardiomyocyte death and maximizing cardiac function.

Public health relevance
PROJECT NARRATIVE This project investigates the role of stress granules—transient cytosolic structures formed in response to cellular stress—in protecting heart cells (cardiomyocytes) during ischemia-reperfusion injury, a condition that damages heart tissue through oxidative stress and inflammation. By studying how stress granules assemble and disassemble in cardiomyocytes under stress and testing their effects on cell survival, this proposal aims to determine whether these condensates are protective, harmful, or incidental. Insights from this work could reveal new therapeutic strategies to reduce heart tissue damage and improve recovery of cardiac function following ischemia-reperfusion injury.